Nucleic Acid Nanoparticle-based Monoclonal Antibody Mimics

ABSTRACT
Therapeutic monoclonal antibodies (mAbs) represent a rapidly expanding class of therapeutic agents, offering
promise for treating various cancers, including prostate cancer (PC). However, their complex structure, elevated
production cost, cross-reactivity, immunogenicity, and instability have limited their utilization in modern medicine
and have prompted exploration for alternatives. Accordingly, nucleic acid aptamers, known for their high affinity
and specificity (functions that mimic mAbs), have recently emerged as compelling substitutes in diagnostic,
therapeutic, and targeting applications. By leveraging the advantages of aptamer technology and utilizing
recently developed modular, enzymatically stable, and non-immunogenic chemically modified triangular nucleic
acid nanoscaffold, a panel of highly stable next-gen NANPs capable of harboring numerous PC-binding
aptamers in controlled manner will be constructed. This design will mirror the structural diversity of mAbs,
including monomers (IgD, IgE, IgG), dimers (IgA), and pentamers (IgM). The enzymatically stable 2’F-modified
RNA aptamer, recognized for its robust binding affinity to Prostate Specific Membrane Antigen (PSMA) on PC
cells, stands as the primary aptamer candidate. In contrast to monoclonal mAbs, the resulting set of NANP-mAbs
bypass the need for animal use in production. Also, compared to mAbs which require storage at -80 °C, the
NANP-mAbs can be stored at room temperature for prolonged periods of time when dehydrated. Utilizing
programmable NANPs synthesized and assembled in vitro ensures remarkable batch-to-batch consistency.
Collectively these factors enable economical, highly accurate, and large-scale production of NANP-mAbs for
both PC detection and treatment purposes.
The long-term objective of this NIH AREA R15 proposal to develop next generation NANP-mAbs platform
applicable to therapeutic interventions across various diseases and particular PC. The three Aims of this
proposal are: 1. To construct and characterize next-gen NANP-mAbs assembled from stable and compact
triangular nanoscaffolds; 2: To evaluate stability of the proposed NANP-mAbs in blood serum and study binding
affinity to PSMA; and 3: To assess binding specificity of these NANPs-mAb to PC cells. The short term goal is
to create a repertoire of nucleic acid-based nanoparticles capable of hosting multiple human PSMA binding
aptamers along with an imaging dye, enabling synergistic and amplified PC-specific binding outcomes to be
achieved. Binding affinities and cellular internalization of proposed set of next-gen NANP-mAbs will be rigorously
compared and then screened for suitability in subsequent studies using in vivo models. Ultimately, the insights
gathered from this innovative project will drive the development of robust Nucleic Acid Nanotechnology platforms
with broad biomedical applications, aligning well with the mission of the National Institute of Biomedical Imaging
and Bioengineering to "transform through technology development, our understanding of disease and its
prevention, detection, diagnosis, and treatment."

Public health relevance
PROJECT NARRATIVE This proposal aims to leverage nucleic acid nanotechnology to create a set of non-immunogenic monoclonal antibody mimics for precise targeting, detection, and treatment of prostate cancer. Utilizing programmable characteristics of modular, thermodynamically and enzymatically stable, and non-toxic triangular RNA scaffold, we will construct various isotypes mimicking structures and binding functions of monoclonal antibodies. The goal is to establish a reliable platform for monoclonal antibody alternatives that can be employed in therapeutic interventions across various diseases.